Rational optimization of combinatorial therapies for the treatment of rare cystic fibrosis variants

Abstract
Cystic fibrosis (CF) is a lethal genetic disease that currently affects ~100,000 people worldwide. CF is caused
by a spectrum of loss-of-function mutations that compromise the biogenesis and/ or function of the cystic fibrosis
transmembrane conductance regulator (CFTR) ion channel, most of which enhance its misfolding and
degradation. Recent drug discovery efforts have yielded a suite of approved small molecule “correctors” that
enhance the expression of misfolded CFTR variants and “potentiators” that restore conductance to CFTR
variants with defective gating. Combinations of these molecules have recently revolutionized the treatment of
the ~90% of CF patients bearing at least one copy of the well-studied ΔF508 CFTR variant, which is highly
penetrant among Caucasians. However, the efficacy of current combinatorial therapies varies widely among the
~10% of patients bearing diverse combinations of rare, uncharacterized CF variants with divergent
pharmacological properties (“theratype”). Efforts to expand the labels of current therapeutics and maximize the
number of treatable CF genotypes, in particular amongst non-white populations, are constrained by the large
number of CF variants and the limited throughput of current methods. Identifying rare CF variants that respond
to therapeutic cocktails is likely to become even more challenging as new correctors and/ or potentiators gain
approval. Addressing this challenge requires new techniques that enable efficient biochemical and/ or
pharmacological profiling of rare CF variants. In the following, we propose to address this challenge with a unique
fusion of emerging genetic, biochemical, and computational methods. We show how deep mutational scanning
(DMS) can be used to compare the effects of correctors on the expression of hundreds of variants in parallel.
Our preliminary findings provide an unprecedented glimpse of the divergent theratypes of CF variants while
identifying numerous variants with unique biochemical and/ or pharmacological properties. We first propose to
expand on these investigations in order to measure the response of the complete set of CFTR2 missense
variants to a panel of structurally diverse corrector molecules. We will then characterize the interactomes of
variants with distinct corrector responses to identify CFTR interactions that antagonize the effects of these small
molecules. We will then fuse CRISPR/ Cas9 technology with DMS to determine how these interactions impact
the spectrum of CF variant theratypes. Using state-of-the-art structural modeling approaches, we will then
identify structural defects in the CFTR protein that are associated with the formation of antagonistic interactions
and deviations in CFTR variant theratype. We will then utilize machine learning to classify CF variants based on
their observed pharmacological properties. Finally, we will assess the effects of approved correctors on the
functional properties of previously uncharacterized variants using industry-standard short-circuit current analysis
in Fischer Rat Thyroid and human airway epithelial cells. Together, these investigations will help expand the list
of treatable CF genotypes and provide new tools to optimize the targeting of CF drugs.

Public health relevance
Project Narrative. Several recently approved therapeutics have revolutionized the treatment of cystic fibrosis, which is a common genetic disease caused by a spectrum of mutations within the CFTR gene. However, the optimal combination of drugs for each patient depends on the nature of their specific genetic variations, and the optimal therapeutic combinations have yet to be determined for the hundreds of known CF mutations. The proposed investigations will utilize a combination of emerging techniques to comprehensively match current medications to these mutations and help to target new drugs as they come to market.